Phase 2 Bridging Pre-transplant Inflammatory Dampening for Primary Immune Regulatory Disorders (BRIDGE Trial)

Abstract
The Primary Immune Regulatory Disorders (PIRDs) are a group of inborn errors of immunity (IEI) that result from
constitutive activation and/or dysregulation of specific immune pathways. There are 130 genes identified to date
that are associated with PIRDs. Each PIRD is extremely rare and the PIRDs in general comprise approximately
5% of IEI. Patients with PIRDs often have multiple life-threatening opportunistic infections, autoinflammatory
conditions and autoimmune sequelae related to the constant activation of their immune system. Given the rarity
of each PIRD and of PIRDs in general there are little if any therapeutic interventions for these patients.
Hematopoietic Stem Cell Transplant (HCT) offers a curative option for many patients with PIRDs. The high levels
of inflammatory mediators in patients with PIRDs however has made it extremely difficult to have successful
outcomes due mostly to graft failure/rejection as well as post-transplant immune complications. Patients with
PIRDs therefore have limited therapeutic options and only those that are most severely affected are considered
for cures with HCT. The BRIDGE Trial is a Phase 2 clinical trial to improve outcomes of curative therapy with
HCT for patients with a PIRD diagnosis. The protocol utilized a biomarker-guided immune suppression prophase
to dampen the inflammatory milieu prior to and during a myeloablative conditioning regimen for HCT. For patients
with PIRDs that result in perturbations of their IFNγ pathway, a prophase of emapalumab, an IFNγ neutralizing
monoclonal antibody will be incorporated prior to and during the conditioning regimen. Patients that have PIRDs
that result in dysregulation of other inflammatory pathways will receive a generalized inflammatory suppression
prophase with fludarabine and dexamethasone, similar to what is currently being used for patients with
hemoglobinopathies undergoing HCT. These targeted inflammatory suppression regimens will provide a more
balanced milieu in patients with PIRDs while they receive conditioning and enable more efficient engraftment,
balanced immune reconstitution and improved outcomes. This dataset will be pivotal to expand indications for
emaplaumab, an orphan drug approved for primary hemophagocytic lymphohistiocytosis (pHLH), to bridging
therapy for curative HCT for IFNγ immune dysregulation syndromes. In aims 2 and 3 we take advantage of our
expertise in immune reconstitution and biomarker discovery studies to provide in-depth correlative biology. Our
focus will center on deep immunophenotyping of reconstituting subsets, identification of soluble biomarkers for
immune mediated complications and to identify mechanisms of how a targeted immune suppression prophase
helps provide an appropriate immune milieu during conditioning and as the hematopoietic system regenerates
after HCT. These studies will provide critical data for continued future clinical trials to provide durable cures to
patients with PIRD diagnoses.

Public health relevance
Project Narrative Primary Immune Regulatory Disorders (PIRDs) are a subset of inborn errors of immunity that cause disease by dysregulation of different immune pathways. PIRDs as a whole and each specific PIRD are rare diseases, most of which have little if any therapeutic options. This proposal aims to provide a novel curative option using immune suppression prior to and during conditioning for bone marrow transplant for patients, to restore their immune system and allow them to live healthy productive lives.